SEER RESEARCH SUPPORT REGISTRIES PROGRAM LINKAGES AND DATA MANAGEMENT SUPPORT

The SEER Research Support Registries Program Linkages and Data Management Support project is designated to increase the research value of the SEER data, with a special emphasis on the National Childhood Cancer Registry (NCCR) program to enhance cancer surveillance data to better understand trends, especially for cancer in children and young adults. This enhancement of the data will in turn support a broader set of research activities in multiple areas.